Peptide Enabled Tunable Restorative Interface

PROJECT SUMMARY
Among U.S. children, caries is the single most common chronic disease and one of the most common unmet
health care needs. Underserved and special needs patient populations have a higher caries burden, i.e.,
untreated dental caries is a major health problem for children with developmental disabilities. Treating carious
lesions conventionally requires surgical removal of diseased tooth structure using high-speed drills and the
accompanying extensive dental restorative treatment for young children or persons with special needs may
require general anesthesia or deep sedation, steps which require referring the child to a dental specialist and
concordant high hospitalization costs. Untreated early childhood caries (ECC) spreads more rapidly compared
to adult teeth and develops both short- and long-term significant health issues. The only noninvasive, efficacious
treatment option in the U.S. for arresting caries is silver diamine fluoride (SDF). SDF was approved by the FDA
in 2014 and granted a breakthrough therapy designation for treating caries in children. However, permanent
black staining of SDF-treated caries lesions limited the acceptability and adoption of this treatment. Besides, the
new interface formed at the SDF site raised concerns regarding reduced bonding of composite materials
commonly used to mask the staining. Recent studies on SDF treatment indicated the formation of silver
complexes filling the cavities and penetrating dentin tubules. This proposal addresses the urgent clinical need
for noninvasive treatment for caries in children and persons with special needs by developing a silver targeting
biomimetic interface that works synergistically with SDF to arrest caries and remineralize the tooth while reducing
silver oxidation which leads to black staining. We hypothesize that polymerizable peptides targeting silver
compounds and acting as remineralization agents will slow silver oxidation, promote tooth remineralization,
enhance properties of SDF-tooth interface and arrest caries. Recent findings from our lab support this hypothesis
and offer significant promise for meeting this urgent need. First, we engineered bifunctional peptides containing
a silver-binding domain (AgBP) that self assembles and mediates remineralization at the SDF treated carious
lesion. Second, we developed a polymerizable AgBP by tethering it to methacrylic acid for use as a peptide-
monomer in dentin adhesive. Third, we demonstrated that self-assembly of the AgBP-monomer at the SDF
treated interface significantly reduces the silver oxidation process. Building on our progress, the proposal
exploits: Aim 1) engineered peptides to improve interface properties by preferentially interacting with silver
complexes and remineralizing the SDF-treated lesions; Aim 2) polymerized peptide-polymer resins to reduce the
Ag oxidation process and provide durable bonding with SDF; Aim 3) co-treatment with SDF and peptide-polymer
resins to provide more-durable, mechanically robust interfacial bonds compared to SDF treatment alone. The
proposed application has the potential to directly impact oral health disparities by arresting caries, remineralizing
the tooth, and reducing the stigmatizing side effect of black staining associated with SDF treatment alone.

Public health relevance
Among U.S. children, caries is the single most common chronic disease and one of the most common unmet health care needs affecting underserved and special needs patient populations. Silver diamine fluoride is the only noninvasive treatment option for children with caries; yet black staining of SDF-treated caries lesions limited the acceptability and adoption of this treatment. This proposal aims to develop a silver targeting biomimetic interface that synergizes with SDF to slow silver oxidation that results in staining, promotes tooth remineralization, and enhances the properties of the SDF-tooth interface for the treatment of childhood caries.